PHASE I STUDY TO EVALUATE SAFETY AND PHARMACOKINETICS OF DMP-840

This is a phase I, dose escalation study of DMP 840 in patients with refractory solid tumors. DMP 840 is a bis-naphthalamide, a unique DNA intercolator which causes single strand breaks in DNA and inhibits DNA synthesis as well.